Training in Visual Neuroscience

DESCRIPTION (provided by applicant): This is a competing renewal application for funds to support pre- and postdoctoral training in visual neuroscience at the Center for Neural Science (CMS) and the Cognition and Perception Program in the Department of Psychology (CP) at New York University. We seek to renew the Training Grant at our historical levels of support, 6 predoctoral fellows and 1 postdoctoral fellow. This support is needed for the training program to maintain itself and to satisfy the needs of a coherent group of trainees. With the help of previous NEI support we have made the Visual Neuroscience Training Program a rich and fruitful unit that has trained many visual neuroscientists who have made important contributions to the field, and some of whom have been strikingly successful in their work. The 18 faculty of the training program seek to understand the visual system from a variety of disciplinary perspectives, with a consistent focus on understanding visual function. The high quality and research orientation of the training faculty, its breadth and productivity, has in the past and will in the future provide a fertile training environment in which young scientists can thrive. There is ample instruction through courses and especially through mentoring in the research labs of CNS and CP that helps bring trainees to the frontiers of vision research. Many active researchers supported by NEI and other agencies provide direction, leadership, and support for students once they emerge as more independent senior students. Extensive shared facilities, including a 3T MRI scanner operated solely for research by CNS and Psychology, facilitate collaborations among faculty and trainees. Three new faculty recruited in the last 6 years have invigorated what was already a good program, making it even better. The students who join the CNS and CP doctoral programs are of outstanding quality. Their training consists of course work, laboratory rotations, seminars and personal interactions with visitors, journal club participation, scientific mentoring and research. The laboratory component of the curriculum includes both hands-on experience with a variety of neurobiological methods in a weekly 6-hour instructional laboratory and also two intensive rotations in research laboratories of members of the training program.